Transcriptional regulation of essential tissues by pioneer factor FoxA in schistosome parasites

Project Summary/Abstract
Schistosomes are parasitic flatworms that cause schistosomiasis, a debilitating disease afflicting over 250 million
people. Current treatment is limited to a single chemotherapeutic, praziquantel, which is only active against adult
parasites, does not prevent reinfection, and has had reports of resistance in schistosomes. This highlights a dire
need for new treatments, and shows that a deeper understanding of the mechanisms schistosomes use to
operate in our bodies is needed to identify new targets for treatment of this disease. We recently discovered
Schistosoma FoxA, a transcription factor that is required for the development and maintenance of the
esophageal gland (EG), which is a specialized digestive organ. RNAi depletion of foxA results in complete loss
of the EG, which renders parasites unable to survive inside of the host. However, the mechanism by which FoxA
regulates transcription, what cofactors are involved in this process, and whether FoxA plays a role in the
differentiation of other tissues remains unknown. In other organisms, FoxA is a pioneer transcription factor that
binds to and opens chromatin, working with specific co-factors to govern cell fate by regulating the accessibility
of certain lineage-associated genes. My preliminary single-cell RNA-sequencing data has revealed that foxA is
expressed in discrete cell types, including a specific population of stem/progenitor cells, the intestine, a sub-
population of neurons, and at lower levels in the EG. Interestingly, the top two genes that correlate with foxA
expression are gata4 and prdm1, which encode transcription factors that are known in other organisms to work
with FoxA to govern cell differentiation. Based on these observations, I hypothesize that schistosome FoxA works
cooperatively with Gata4 and/or Prdm1 on enhancers of different lineage-specific genes to alter chromatin
accessibility, thereby regulating the differentiation of foxA+ stem cells into physiologically important parasite
tissues. To test this, I will identify the genes and chromatin regions regulated by FoxA using single-nuclei multi-
omics of control and foxA RNAi parasites (Aim 1) and define the roles of Gata4 and Prdm1 in parasite tissue
maintenance and survival in the host using RNAi coupled with high-resolution imaging and robust in vivo assays
(Aim 2). This work will elucidate the molecular mechanisms by which FoxA regulates the development of
essential parasite tissues, aiding in the identification of parasite factors with potential to be targeted for treatment
of this disease. Together with Dr. Jayhun Lee (sponsor) and Dr. Ambro van Hoof (co-sponsor), I have created a
plan to achieve the work proposed here, as well as develop my skills and transition to a post-doctoral fellowship.
As such, the Lee lab and UTHealth Houston provide the ideal environment to hone both my research and
professional skills, helping me to achieve my long-term goal of becoming a successful independent researcher.

Public health relevance
Project Narrative Schistosomes are human parasites that infect over 250 million people and rely on a population of stem cells that drive their development and pathogenesis. This project aims to uncover the molecular mechanisms by which the transcription factor FoxA regulates the differentiation of these stem cells into essential parasite tissues. This work will lead to an increased understanding of the developmental strategies employed by these parasites to survive inside of human hosts, and will identify parasite factors that may have potential to be targeted for treatment of this disease.